CLINICAL AND BIOCHEMICAL MARKERS OF OSTEOPOROSIS IN CYSTIC FIBROSIS

To determine the prevalence of osteoporosis in adults in cystic fibrosis and investigate the effect of specific correlates for bone mineral density (BMD) in adult patients with cystic fibrosis.